Mechanisms of swallowing dysfunction and rescue in a translational rat model of Alzheimer's disease

Abstract
Dysphagia is a major consequence of Alzheimer’s disease (AD) that is understudied and thus undertreated
despite high prevalence and high cost to heath care systems. Pathology in AD (inflammation, amyloidosis,
phosphorylated tau) occurs in the central and peripheral nervous systems early in disease progression and in
brain regions and muscle systems associated with swallowing functions. Barriers to effectively treating
dysphagia in AD are the lack of: (a) an understanding of central and peripheral pathology associated with
dysphagia, and (b) controlled studies of interventions at crucial timepoints, including early versus later in the
disease process. The proposed research is significant in addressing these barriers and rigorous in that we
will apply established translational research approaches currently used in our labs in models of aging and
Parkinson disease. Our scientific premise is that pathology in AD occurs in the central and peripheral nervous
systems early in disease progression and that exercise interventions can mitigate deficits induced by the
presence of pathology and potentially change the course of sensorimotor decline in function. Because tongue
muscles are primary actors in the swallowing process, our central hypotheses are that pathology manifests in
tongue muscle and brainstem, subcortical, and cortical regions associated with oropharyngeal swallowing and
that early implementation of tongue exercise leads to better swallowing outcomes. We will gain insight into
mechanisms by using the well-established TgF344-AD rat model and conducting physiological, morphological,
bioenergetic, neuroimaging, and behavioral assays in the brain and tongue muscles. Feasibility data show the
oromotor and swallowing dysfunction, evidence of inflammation in the brainstem, and increased beta-amyloid
in brain regions associated with swallowing in 12-month-old TgF344-AD rats. The tongue exercise intervention
is modeled after those used in clinical practice. However, these clinical protocols are not optimized due to
barriers in human research, such as presence of co-morbidities, adherence confounds, and limited access to
tissues. Aim 1 will test the hypothesis that TgF344-AD rats demonstrate deficits in oromotor and swallowing
behaviors and manifest pathology in tongue muscles and brain structures critical to swallowing function. Aim 2
will test the hypothesis that early implementation of tongue exercise improves oromotor and swallow function
and modulates pathology in TgF344-AD rats. This research is innovative and will provide a new
understanding of mechanisms that underlie swallowing deficits in AD, query relationships among relatively
unexplored AD pathology and physiological function in swallow-related systems, and establish the
effectiveness of early versus late tongue exercise intervention for AD. Rehabilitation is often not provided to
patients with AD due to uncertain benefit. To advance evidence-based treatment, we must provide preclinical
data. This foundational work has a high impact because of the large and increasing population of people
with AD-associated dysphagia who can benefit from treatments optimized in the proposed studies.

Public health relevance
Narrative Swallowing problems in Alzheimer’s disease cause significant health and quality of life issues. This translational research establishes whether tongue exercise started earlier or later in the disease process significantly improves swallowing function and changes AD-related pathology in tongue muscles and associated brain regions.